Role of the Viral Capsid in HIV-1 Integration

ABSTRACT
The ongoing HIV pandemic has resulted in ~1.2 million infections in the US and ~37 million infections
worldwide. In spite of considerable progress in HIV/AIDS research, anti-retroviral therapy (ART) remains the
only treatment option for HIV-1 infection. While ART has been highly effective in controlling the virus and
making HIV infection a manageable disease, the drugs used in the ART regimen are expensive, cause side
effects, and face viral resistance. Thus, there is an urgent need for continued development of drugs against
novel cellular and viral targets. HIV-1 capsid protein (CA) is an important viral therapeutic target that is
currently clinically unexploited. Recently, Gilead developing a highly potent CA-targeting inhibitor as next
generation of antivirals. However, successful transition of these CA-specific inhibitors to the clinic require clear
understanding of the anti-viral mechanisms and the delineating CA’s role in HIV-1 infection. Our studies are
designed to understand the mechanism by which HIV-1 CA controls viral integration.
HIV enters the target cell by fusion of the viral membrane with the cellular membrane, releasing the
viral capsid core into the cytoplasm of the target cell. Functional studies of HIV-1 variants indicate that the
proper assembly, morphology, and stability of the capsid core are all essential for HIV-1 infectivity. While it is
well established that HIV-1 CA facilitates reverse transcription, recent data shows that CA is also a key
determinant of the ability of HIV-1 to enter the nucleus of the target cell. In particular, CA is genetically and
functionally implicated in nuclear entry of the reverse transcribed provirus, by mediating interactions with
cellular factors. A key knowledge gap is the role of CA in viral integration-a critical post-nuclear entry step of
HIV-1 infection. We hypothesize that HIV-1 CA protein directly influences viral DNA integration. To test
this hypothesis we propose three specific aims: Aim 1. To define the effects of capsid stability on HIV-1
preintegration complex (PIC) activity and viral DNA integrity. Aim 2. To determine whether integration activity
is dependent on CA levels in the PICs. Aim 3. To determine the role of known capsid-binding host proteins in
defining PIC-associated CA levels and PIC activity. To test a direct link between HIV-1 CA and viral DNA
integration, we have developed a novel model by coupling a biochemical approach that quantitatively
measures PIC-associated integration activity to the use of the CA-specific inhibitor as probes. In addition, we
have assembled a multidisciplinary team with expertise in PIC biochemistry (Dash), capsid biology (Aiken) and
retroviral integration (Engelman). Therefore, the proposed studies will generate new knowledge on the
mechanism by which CA regulates HIV-1 integration and define the antiviral effects of CA-inhibitors to facilitate
the development of novel CA-based anti-viral therapies (a High-Priority HIV/AIDS research area of the NIH).

Public health relevance
PROJECT NARRATIVE The HIV-1 capsid is an emerging anti-viral drug target that is clinically not exploited. The overall goal of this application is to dissect the mechanism by which viral capsid controls HIV-1 integration and generate new knowledge that will promote development of HIV-1 capsid based anti-viral therapy.